CELL SURFACE RECEPTORS FOR IGE

The high affinity receptor for IgE on mast cells and basophils plays a central role in immediate hypersensitivity reactions. Crosslinking of bound IgE by polyvalent antigen leads to aggregation of the receptors and cellular secretion of both preformed and newly synthesized mediators of inflammation. The molecular mechanisms by which aggregation of the receptors generates cellular responses are still largely undefined. During the past year we have continued to employ mutated receptors in order to analyze which portions of the receptor participate in its principal functions. Our new results show: 1) None of the cytoplasmic domains are required for receptors to exhibit detergent-insolubility after aggregation. Indeed, lipid-anchored ectodomains of the alpha subunit are sufficient to demonstrate this effect. 2) A receptor-less mast cell-like line has been successfully transfected with various mutant receptors and studied with respect to the early biochemical events associated with aggregation of the wildtype receptors for IgE. Truncation of the cytoplasmic domain of the alpha subunit or at the amino-terminus of the beta subunit failed to inhibit signalling. Truncation of the gamma chains also led to loss of functions. In this case the receptors for IgG were also inactivated possibly because the functionally active receptors are of the type that contain gamma subunits. Surprisingly the inactive IgE receptors were found to contain normal amounts of the wild type (endogenous) gamma chains. This suggests that the transfected mutant gamma chains had a negative dominant effect.